Preventing Medication Mismanagement in People Living with Dementia through Automated Medication Dispensing with Facial Recognition and Video Observation

Globally, >47M individuals live with dementia, with new incidence of 7.7M annually. Medication
mismanagement is one of the most common and concerning risk factors in people with dementia (PwD), as it
leads to undertreatment, emergency room visits, hospital admissions/readmissions, and serious adverse events.
3M older U.S. adults are admitted to nursing homes due to drug-related adherence problems with costs
>$14B/year. Furthermore, 30% of hospital admissions of older adults are drug related with 11% attributed to
medication non-adherence and 17% to adverse drug reactions. While Alzheimer’s disease (AD) & type 2
diabetes mellitus (DM) individually have considerable morbidity & mortality, they often occur together, worsening
adverse outcomes, quality of life, & care costs. This is especially true as the AD/DM combination creates a
complex balancing act of med management & symptom monitoring in older populations. While the goal is to
keep older adults with dementia at home as long as possible, these challenges lead to untold personal & family
suffering, as well as billions in potentially avoidable healthcare costs annually.
The HiDO-ALZ platform will solve these challenges by automating medication administration for PwD to
eliminate mismanagement, decrease caregiver burden, reduce healthcare utilization, and facilitate PwD to age
in place. HiDO is being developed as an automated, AI driven medication dispensing and direct observation
platform to optimize adherence. The device integrates medication dispensing, dose administration time,
medication synchronization, & pair of front-facing cameras to validate the right meds, right route, right time, right
dosage to the right patient (5R’s). Cameras record every dose using facial recognition & provide real-time
medication consumption recordings. Through cloud connectivity, providers & caregivers have access to video
observation logs, dose administration time, adherence trends, & longitudinal adherence via web dashboard.
Patients & caregivers can easily setup complex medication protocols in minutes using a smartphone app. The
device then alerts patients and dispenses up to 7 different types of meds simultaneously, with up to 90 days of
medication. Connected data sources including remote blood pressure and weight measurements, as well as
electronic health record lab results and videoconferencing integrate in a single dashboard.
The project will build on successful Phase I, in which the medication dispensing unit was updated with
modifications for dementia, passed all bench testing, and was successfully validated in pilot usability with
dementia subjects. Phase II will expand the foundation with four Aims: 1) Enhance device with remote sensors
for diabetes management, expanded data integration, and video conferencing, 2) Test enhanced platform for
usability in dementia subjects, 3) Transition the design to formal manufacturing process to ensure system meets
performance standards and regulatory requirements & produce pre-production devices for testing, & 4) Conduct
in-home clinical trial to demonstrate adherence and efficacy.

Public health relevance
The Phase II SBIR goal is to enhance, validate, & commercialize HiDO-ALZ, an automated, secure, artificial intelligence (AI) driven medication delivery & observation platform to maximize therapy compliance & health outcomes in dementia. Dementia and Alzheimer’s disease (AD) negatively impact medication management, especially when type 2 diabetes mellitus (DM) occurs as a comorbidity. Development of novel AI technology to improve independent patient adherence to complex medication schedules and remote reporting of compliance metrics to caregivers & providers would significantly optimize patient care and reduce healthcare costs.